NEURAL MECHANISMS UNDERLYING MBSR IN HEALTHY AND SOCIALLY PHOBIC INDIVIDUALS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The overall goal is to identify the neural mechanisms associated with Mindfulness-Based Stress Reduction (MBSR). Clinical research has shown that MBSR reduces psychological distress and increases well-being, but the mechanisms underlying these changes in not well described. Basic research has examined the neural bases of emotion and emotion regulation, but this research has not examined changes following MBSR. To read about other projects ongoing at the Lucas Center, please visit http://rsl.stanford.edu/ (Lucas Annual Report and ISMRM 2011 Abstracts)